Investigating fibrinogen as a pathologic and targetable mediator of COVID-19-associated coagulopathy

Severe COVID-19 remains a top ten leading cause of death in the United States and is a major risk factor for
the development of post-acute sequelae of SARS-CoV-2 infection (PASC, or long COVID). Despite tremendous
strides in preventing and mitigating COVID-19 through vaccines and antivirals, strategies for managing critical
illness in patients who nevertheless develop severe disease are insufficient. This is in large part due to an
incomplete understanding in the mechanisms driving severe disease, of which COVID-19-associated
coagulopathy is believed to be a major mediator. At the beginning of the pandemic, we reported elevated blood
viscosity in critically ill COVID-19 patients related to hyperfibrinogenemia. More recently, our mechanistic studies
uncovered a unique mechanism by which pathologically elevated fibrinogen causes the formation of red blood
cell aggregates that mechanically injure the vascular endothelium. Fibrinogen is an essential clotting factor
induced as part of the hepatic acute phase response during inflammation; yet, fibrinogen levels are not affected
by currently available anticoagulant therapies. Thus, our findings help to explain the link between inflammation
and clotting in COVID-19, including the increased risk of macrovascular thrombosis and the decreased
microcirculatory perfusion of critical organs, even in patients receiving anticoagulation. Since therapeutic plasma
exchange (TPE) is the recommended intervention for treating hyperviscosity in other conditions, we initiated a
small randomized controlled trial to determine the safety and efficacy of TPE for COVID-19 patients with
hyperfibrinogenemia, and banked biospecimens for future study. Here we propose a series of experiments
testing the central hypothesis that fibrinogen is a pathologic and targetable mediator of COVID-19-associated
coagulopathy. Specifically, in Aim 1 we propose to define the impact of TPE on blood rheology and vascular
integrity by interrogating the molecular signatures of plasma samples from COVID-19 patients before and after
the procedure. In addition, we have identified significant elevation in a variant fibrinogen isoform, g ¢ fibrinogen,
in COVID-19 patients, which is most pronounced in those developing acute thrombosis. This usually minor
fibrinogen isoform has unique biochemical properties, most notably its substantial negative charge, expected to
exaggerate alterations in blood rheology. Thus, in Aim 2 we propose to define the impact of g¢ fibrinogen on
biophysical properties of red blood cells and thrombosis in COVID-19. Together, these aims will not only advance
our understanding of critical illness and acute coagulopathy in COVID-19, but also may have relevance for PASC
and other non-COVID-related conditions involving thromboinflammation. Finally, as an extension of the K99
work, the R00 will afford a protected transition period critical to facilitating R01-readiness and to establishing an
independent blood sciences research program.

Public health relevance
Severe COVID-19 remains a top ten leading cause of death in the US and is a major risk factor for developing long COVID. We recently uncovered a pathway that links inflammation with abnormal blood flow in severe COVID-19, which contributes to blood clots and organ failure. In this study we propose to investigate the factors responsible for this process and the ability of a procedure called plasma exchange to correct abnormal blood flow.